The Tobacco and Cannabis Retail Environment, Neighborhood Disadvantage, and Adolescent Vaping

PROJECT SUMMARY
There is a growing marketplace for e-cigarettes and legal cannabis vaping products that appeal to adolescents.
Adolescent nicotine and cannabis vaping is prevalent, co-use of nicotine and cannabis vaping is common, and
many youth purchase vaping products from physical retailers (e.g., vape shops and dispensaries). Greater
density of tobacco and cannabis retailers around adolescents’ homes and schools may influence youth vaping
initiation and dependence via increased access and exposure to marketing. Nicotine and cannabis vaping are
intertwined, and the tobacco retail environment may influence youth cannabis vaping, and vice-versa. However,
few studies have examined the effect of retailer density on youth nicotine and cannabis vaping, including whether
tobacco retail density influences cannabis vaping, and whether cannabis dispensary density influences nicotine
vaping. Data are also lacking on whether the impact of retailer density on youth cannabis and nicotine vaping is
disproportionately higher among those living in disadvantaged neighborhoods, leading to disparities in cannabis
and tobacco use. The goal of this Mentored Research Scientist Career Development Award is to investigate the
impact of the tobacco and cannabis retail environment and neighborhood disadvantage on adolescent nicotine
and cannabis vaping, and to provide new training to prepare me for a career as an independent investigator with
a focus on tobacco and cannabis regulatory science, and the ability to secure R01-level funding. I will use four
years of data from an ongoing prospective cohort study of high school students in Southern CA (N~4,000),
alongside data on licensed and unlicensed tobacco retailers and cannabis dispensaries, and census-block
measures of neighborhood disadvantage to evaluate the project aims: (Aim 1) to examine the association of
tobacco retailer and cannabis dispensary density with adolescent nicotine and cannabis vaping; (Aim 2) to
assess the moderating role of individual- and neighborhood-disadvantage on the association of tobacco retailer
and cannabis dispensary density with adolescent nicotine and cannabis vaping; and (Aim 3) to collect new data
through in-depth store observations in a geographic subsample to identify specific store characteristics (e.g.,
marketing, minimum-age verification, product availability) that contribute to adolescent nicotine and cannabis
vaping. Findings will provide critically needed information to policymakers considering new regulations that
protect the public health of youth. This work will also inform future research on additional dimensions of tobacco
and cannabis policies (e.g., home deliveries, pricing) and their impact on youth tobacco and cannabis use on a
national level. This K01 leverages my existing expertise and addresses critical gaps in my training by providing
new training in: 1) cannabis regulatory science; 2) socioecological determinants of youth tobacco and cannabis
use; and 3) spatial analysis. I have worked closely with my mentors (selected based on their expertise in each
training area) to develop an ambitious but feasible training plan that incorporates expert mentoring, coursework
and seminars, scientific meetings, and continued development of grant writing and research dissemination skills.

Public health relevance
PROJECT NARRATIVE Many youth purchase nicotine and cannabis vaping products from brick-and-mortar retailers (e.g., vape shops and dispensaries) which are disproportionately located in more disadvantaged neighborhoods; however, it is unknown whether density of tobacco and cannabis retailers around adolescents’ homes and schools is associated with youth vaping initiation and dependence, and whether associations are exacerbated for youth living in areas densely concentrated with both tobacco and cannabis retailers. This K01 award will use multiple existing data sources and new data from store observations to investigate the impact of the tobacco and cannabis retail environment and neighborhood disadvantage on adolescent nicotine and cannabis vaping. This work can inform regulations to prevent vaping and its harms for youth and will prepare the PI for independent R01 research that examines geospatial and regulatory determinants of youth nicotine and cannabis use.